Neuroimaging Methods for Diagnosis of Mild Traumatic Brain Injury

DESCRIPTION (provided by applicant): Abstract / Project Summary Mild traumatic brain injury (mTBI) is a source of major morbidity in recent veterans who served in Iraq and Afghanistan. There has been keen interest in using diffusion tensor imaging (DTI) to assess white matter damage associated with mTBI. The goal of this proposal is to provide quantitative assessment and visualization of white matter damage in a single subject that is based on comparison to a large reference group of non-TBI veterans. Our approach involves performing a whole-brain analysis to create an FA (fractional anisotropy) map that is suggestive of white matter injury in a single subject by comparison to mean FA from a reference group of 100 subjects. We propose primary and confirmatory analytic methods for significance testing: (i) using a method of non-parametric statistics known as permutation testing followed by a novel threshold-free correction for multiple comparison testing, and (ii) using population based inferential statistics to compute whole brain Z-statistic map followed by more typical cluster-based correction for multiple comparisons. Our preliminary data suggests that white matter damage can be effectively assessed in single subjects. Thus, our proposal moves beyond the conventional application of DTI to mTBI research for making group comparisons. If successful and then confirmed in a larger scale study, the approach we propose would provide objective evidence of injury for diagnosing individual patients with mTBI in the clinical setting. PUBLIC HEALTH RELEVANCE: Project Narrative Mild traumatic brain injury (TBI) has had detrimental impact on the health and well-being of OEF/OIF veterans. However, the diagnosis and treatment of mild TBI has been challenging because of significant overlap with PTSD and depression. There has been keen interest in using advanced MRI methods called diffusion tensor imaging (DTI) to assess damage to brain tissue in mild TBI. Traditionally, DTI has only been used in research to draw general conclusions about patients with mild TBI but has not focused on assessment of individual patients. The proposed research program will investigate the use of DTI to visualize brain injury in individual veterans to aid in the diagnosis of mild TBI. If our approach is successful, DTI could be used for evaluation of mild TBI in the clinic.

Public health relevance
Project Narrative Mild traumatic brain injury (TBI) has had detrimental impact on the health and well-being of OEF/OIF veterans. However, the diagnosis and treatment of mild TBI has been challenging because of significant overlap with PTSD and depression. There has been keen interest in using advanced MRI methods called diffusion tensor imaging (DTI) to assess damage to brain tissue in mild TBI. Traditionally, DTI has only been used in research to draw general conclusions about patients with mild TBI but has not focused on assessment of individual patients. The proposed research program will investigate the use of DTI to visualize brain injury in individual veterans to aid in the diagnosis of mild TBI. If our approach is successful, DTI could be used for evaluation of mild TBI in the clinic.